S1P-S1PR1 in bidirectional Neuron-Astrocyte communications

Project Summary/ Abstract
Though synapses are formed between neurons, these structures are contacted with, ensheathed, and
regulated by astrocytes. Period of neuronal synaptic connectivity and that of astrocyte maturation overlaps in
developing brain. Neuronal signals instruct astrocyte differentiation and morphological maturation whereas
astrocytes provide metabolic and trophic factors to support neuronal survival and growth. However, molecular
mechanisms and signals that regulate neuron-astrocyte interactions and their role in neuronal circuit assembly
and functions are largely unknown. We and others have previously shown that astrocytes modulate specific
neural circuit formation, function and plasticity by several secreted proteins including hevin (SPARCL1),
thrombospondins (TSPs), glypicans and norrin. While hevin is needed for assembly and plasticity of VGlut2+
(vesicular glutamate transporter 2) thalamocortical connections, TSPs facilitate VGlut1+ synapse formation.
Intriguingly, expression of these synaptogenic proteins is developmentally regulated and are also altered in brain
pathologies. Although a significant amount of research has been done to identify the neuronal receptors and
mechanism of synapse formation by astrocyte-secreted synaptogenic factors SPARCL1 and TSPs, we do not
know the signals and mechanisms that regulate their expression in astrocytes.
We have recently found that neuronal contact stimulates expression of SPARCL1 and TSP4 via Sphingosine-
1-Phosphate (S1P)-S1P Receptor 1 (S1PR1). We also found that S1PR1 is primarily expressed by astrocytes
and is localized to the fine astrocytic processes near and around the synapses and drives astrocyte
morphological complexity and morphogenesis. Although, S1P-S1PR signaling is a drug target for many
neurological disorders, its fundamental role in neuron-glia interactions and neuronal circuit assembly is not
known. Our proposed studies will provide novel insight into the neuron-astrocyte bidirectional communication
through S1P-S1PR1 axis in establishing synaptic connectivity and functions. Our detailed mechanistic studies
will identify new signaling pathway downstream of S1P-S1PR1 axis in regulating calcium dynamics, glutamate
sensing and expression of SPARCL1 and TSP4 in astrocytes. These studies will also advance our knowledge
of how neurons regulate astrocyte development, morphogenesis and function. Moreover, these studies will
decipher the mechanistic link between levels of S1P and the expression of SPARCL1 and TSP4 and clarify on
the fundamental role of S1P/S1PR1 axis in the developing and diseased brain. This proposal thus is poised to
provide novel mechanisms of targeting S1P/S1PR1 axis in alleviating neuropathologies.

Public health relevance
Astrocytes, the most abundant glial cells in the central nervous system, perform a multitude of evolutionary conserved functions including, metabolic support to neurons, regulating blood-brain barrier, and modulating synapse-formation, -function and -plasticity, and are crucial in maintaining normal brain homeostasis. Dynamic crosstalk between astrocytes and neuronal synapses modulates most if not all of these functions, yet the molecular mechanism of neuron-astrocyte cross-communication at the synapse is largely untapped. Based on our preliminary studies, we propose a novel mechanism of neuron-astrocyte crosstalk at the synapse via S1P/S1PR1 signaling that regulates astrocyte function and neuronal synapse formation, function and plasticity.